miR-130b, angiogenesis, and diabetic critical limb ischemia

Peripheral artery disease (PAD), an arterial occlusive disease that impedes blood flow to the lower extremities,
can develop into critical limb ischemia (CLI), characterized by chronic ischemic rest pain with high risk for
amputation and cardiovascular complications. Patients with diabetes are disproportionally afflicted by both
PAD and CLI with limited medical interventions to improve limb perfusion. Angiogenesis is impaired in diabetic
patients and the mechanisms controlling this process are not fully understood.
MicroRNAs (miRNAs) are small, non-coding RNAs capable of repressing gene expression and are
involved in a variety of pathophysiological processes with important therapeutic potential, though their role in
angiogenic signaling pathways in diabetic CLI remains poorly defined. Because miRNAs exhibit high
conservation across species, sequencing of miRNAs from the plasma of human subjects with diabetes and
increasing severity of PAD and diabetic mice with limb ischemia was used to identify overlapping, new miRNA
targets including a top candidate miR-130b. Preliminary gain and loss-of-function studies revealed that miR-
130b overexpression rapidly promoted proliferation, migration, and sprouting in endothelial cells (ECs),
whereas miR-130b inhibition exerted anti-angiogenic effects. ECs exposed to high glucose downregulated
miR-130b and co-transfection of miR-130b under high glucose conditions accelerated EC wound closure.
Local delivery of miR-130b mimics into ischemic muscles of diabetic db/db mice following femoral artery
ligation (FAL) promoted revascularization by increasing angiogenesis and markedly improved limb necrosis
and amputation. Mechanistically, overlapping downregulated transcripts from RNA-seq and miRNA prediction
algorithms identified that miR-130b directly targeted and repressed inhibin-b-A (INHBA), a subunit involved in
the formation of activin A, and downstream Smad2 signaling. Indeed, ectopic delivery of siRNA targeting Inhba
in db/db ischemic muscles following FAL improved revascularization and limb necrosis, recapitulating the
phenotype of miR-130b delivery. These observations provide the foundation for the central hypothesis that the
miR-130b-INHBA signaling axis may serve as a critical regulator of EC angiogenic responses for patients with
PAD and diabetes at risk of developing CLI. To better understand the precise role of miR-130b in INHBA
signaling and angiogenesis, we will in Aim1 delineate the molecular basis for miR-130b’s ability to regulate
INHBA signaling and EC angiogenic functions. In Aim2, we will determine the effect of altered miR-130b
expression in experimental critical limb ischemia in diabetic mice. Finally, in Aim3 we will assess the
expression of the miR-130b-INHBA signaling axis in a unique cohort of human subjects with CLI with or without
diabetes. Our studies will address a major gap in our understanding of diabetic CLI and inform how miR-130b-
INHBA mediated control of EC angiogenic functions may provide new targets for therapy.

Public health relevance
Narrative: Despite current therapeutic strategies, human subjects with diabetes and peripheral artery disease (PAD) suffer from an increased risk of critical limb ischemia (CLI), a more severe condition associated with impaired growth of new blood vessels, ischemic rest pain, impaired wound healing, and a higher risk of limb amputation and cardiovascular death. We have identified a novel pro-angiogenic microRNA, termed miR-130b, in both mice and human subjects with diabetes and increasing severity of PAD. The proposed studies will provide a detailed understanding for how miR-130b promotes critical angiogenic signaling pathways and functional responses in ischemic limbs with the goal of developing novel therapies for overcoming “angiogenic resistance” in the treatment of diabetic critical limb ischemia.